Health Care Access, Quality, and Outcomes among Individuals with Dementia in Dual Eligible Special Needs Plans

Addressing the long-term care needs of a growing number of older individuals with Alzheimer's disease and
related dementias (AD/ADRD) is one of the most daunting challenges facing the U.S. public health safety net.
AD/ADRD is one of the most expensive categories of chronic conditions in the U.S. Older adults with AD/ADRDs
have complex long-term care needs for medical, behavioral, and social supports. Medicaid is the public program
that is chiefly responsible for paying the costs of long-term care supports and services (LTSS) for older adults
with AD/ADRD who have exhausted their resources and ability to pay for needed long-term care. A growing
trend in Medicaid programs has been to support older individuals with AD/ADRD at home rather than in nursing
homes by offering Medicaid enrollees greater access to Home and Community Based Services (HCBS) services,
such as in-home personal care services and case management. The rapid rise of Medicaid HCBS and home-
based AD/ADRD care has served to highlight a growing problem of lack of coordination of Medicaid HCBS and
other needed chronic care management services by duals’ primary health insurance carrier, which is Medicare.
The long-term goal of this project is to provide an evidence base for viable solutions to this Medicare-Medicaid
coordination problem. Medicare Advantage (MA) Dual Eligible Special Needs Plans (D-SNPs) are private
managed care plans that only enroll dual eligible individuals. A special type of integrated D-SNP that combines
Medicare Advantage and Medicaid benefits under one managed care provider may result in better care
coordination, longer community tenure, less nursing home use, and improved health outcomes among older
disadvantaged individuals with AD/ADRD. This project uses nationwide linked Medicare-Medicaid administrative
data to compare the effectiveness of integrated D-SNPs to non-integrated D-SNPs among duals with AD/ADRD
based on the results of three analyses. The first analysis compares HBCS use among duals with AD/ADRD in
integrated and non-integrated D-SNPs; the second analysis compares in-home service and prescription drug
process quality indicators among duals with AD/ADRD in integrated and non-integrated D-SNPs; and the third
analysis compares nursing home use, community tenure, and plan disenrollment among duals with AD/ADRD
in integrated and non-integrated D-SNPs. This project uses linked Medicare and Medicaid managed care
encounter data from the years 2021-2023. The final project dataset will contain over 150,000 year-quarter
observations on D-SNP enrollees from over 250 unique D-SNPs. This project will be among the first to
comprehensively describe both Medicaid and Medicare service use among duals with AD/ADRD. With
assistance from project partners, the results will be disseminated to a broad stakeholder audience of Medicaid
officials, the Centers for Medicare and Medicaid Services (CMS), and policy advocates for individuals with
AD/ADRD conditions.

Public health relevance
This assesses whether integrated Dually Eligible Special Needs Plans (D-SNPs) in Medicare offer adults living with Alzheimer’s disease and Alzheimer’s related dementias (AD/ADRD) improved long-term care coordination and better outcomes compared with non-integrated D-SNPs. The results of this project will be used to inform state Medicaid policy decisions regarding D-SNP implementation in their states and also will help individuals with AD/ADRD and their families select a Medicare Advantage health plan that best meets their individualized needs.